Population, Life Course and Aging

Abstract
We propose to continue and improve the NIA training program on “Population, Life Course and Aging” located
in the Center for Demography of Health and Aging (CDHA) at the University of Wisconsin-Madison (UW). The
training program builds on the resources of CDHA to form a long-standing, highly-visible core of research and
training in population aging and health at UW. The program draws from a large pool of talented and highly
qualified students in the social sciences and public health, and benefits from the rich interdisciplinary
environment that integrates research and teaching across the departments of Sociology, Economics, and
Population Health Sciences, as well as the La Follette School of Public Affairs, Alzheimer’s Disease Research
Center, the Institute on Aging, the Center for Demography and Ecology, and other centers and programs at
UW. The goal of the CDHA training program is to recruit, develop, support and place productive and
innovative researchers with expertise in demographic methods and statistical analysis who approach the study
of aging from a life course perspective. The current emphases of the program reflect the research strengths of
our faculty: biodemography; the lifetime determinants of cognitive health; and the role of social, economic,
geographic, environmental, and institutional factors in shaping health and health disparities in later life. The
training program also capitalizes on several locally-designed large-scale surveys that combine innovative
biological and social measurements and provide opportunities for training at multiple forefronts of research on
population, aging, and health across the life course. Our program cultivates trainees’ professional skills,
including the conceptualization, execution, presentation, publication, and critique of research via a (1) rigorous
methodological and substantive coursework, (2) research apprenticeships that allow trainees to begin
collaborative research and publication from the start of the program; (3) specialized interdisciplinary research
working groups; (4) professional development seminars ongoing support for developing individual research
agendas, presenting at conferences, publishing papers, and developing grant proposals; (5) close mentoring
relationships between trainees and preceptors; and (6) access to local and national workshops and
professional meetings. We request support for 4 predoctoral trainees (who will generally be supported for 3
years) and 1 postdoctoral trainee (who will generally be supported for 2 years), a level equal to our current
number of positions. This support is essential for sustaining a critical mass of trainees and training-related
research activity. Our students have an excellent record and graduates embark on careers that contribute
substantially to research, education, and public service in the areas of population aging and health.

Public health relevance
Project Narrative The Center for Demography of Health and Aging at the University of Wisconsin-Madison offers outstanding research training in the demography of health and aging, enriched by several locally-designed large-scale surveys that combine innovative biological and social measurement and provide opportunities for training at multiple forefronts of research on population, aging, and health across the life course. Our trainees receive interdisciplinary training in the social and health sciences and enter research careers in academic institutions and governmental health and statistical agencies. Their research and public service increases the understanding of complex biosocial determinants of health in aging populations and influences national policies that affect the health and well-being of all Americans.